Dose-Dependent Functional Connectivity Effects of Low-Intensity Focused Ultrasound Applied to Deep White Matter Tracts in Humans

PROJECT ABSTRACT
Low intensity focused ultrasound (LIFU) is a novel technique producing noninvasive, reversible, and
anatomically precise neuromodulation of deep structures in the brain. Thus far, it has been successfully
employed in humans to modulate the activity of gray matter hubs, including amygdala, thalamus, and cerebral
cortex. Burgeoning in vitro data shows that LIFU is also a powerful modulator of axonal conduction, by
operating mechanosensitive TRAAK potassium channels in nodes of Ranvier. In a recently completed pilot
study (NCT 05697172; FDA non-significant risk), we translated those findings to human subjects by applying
LIFU to deep brain white matter tracts, reasoning that a successful study would allow the modulation of large-
scale brain circuits and thus potentially explore their mechanistic relationship with normal and abnormal
behavior. Specifically, we observed that a single sonication applied to tracts traversing the anterior limb of the
internal capsule (ALIC) produces a functional disconnection of the connected gray matter regions, as assessed
with resting-state functional magnetic resonance imaging (fMRI). Now we propose to define the dose-
dependent effects of LIFU applied to white matter tracts regarding both intensity and duration of its
neuromodulatory effects. We plan to study 60 healthy adults who will be randomly exposed to two different
doses of LIFU applied to tracts connecting the thalamus with the subgenual cingulate (SGCC) and orbitofrontal
(OFC) cortices, namely one and three LIFU epochs (as employed in our pilot study: 80 s duration; 2.26
Watt/cm2 derated tissue peak pulse average intensity; 10% duty cycle, 500 kHz). The target white matter tracts
will be defined in each individual participant by means of probabilistic tractography. The Aim 1 of this proposal
is to determine the relationship between LIFU dose and intensity of target engagement in terms of decreased
fMRI functional connectivity between the gray matter regions connected by the sonicated white matter tracts
(i.e., thalamus and both SGCC and OFC). Aim 2 is to determine the influence of baseline structural (number of
connecting streamlines) and functional (fMRI connectivity) on the dose-dependent LIFU modulation effects. In
Aim 3 we will determine the duration of the neuromodulation effect of the two different doses of LIFU. A
successful study will result in the definition of dose-response relationships between white matter LIFU
modulation and engagement of the targeted brain circuit. This will pave the way for the development of
mechanistic studies consistently linking aberrant function of large-scale brain circuits and basic behavioral
processes, with the long-term goal of improving the definition of precision neuromodulation targets in
treatment-resistant depression and other psychiatric disorders.

Public health relevance
PROJECT NARRATIVE Low-intensity focused ultrasound (LIFU) has emerged as a tool to modulate the activity of deep brain structures noninvasively and reversibly, with anatomical precision. Following the results of a pilot study in which we observed target engagement when LIFU was applied to the anterior limb of the internal capsule, we now propose to determine the dose-response relationships of LIFU when applied to deep white matter tracts of the human brain. We hope a successful study will be rapidly translatable into clinical trials seeking to understand mechanistic brain circuit-symptom relationships in major psychiatric disorders.